Gene Regulation and Physiology of Oral Streptococci

PROJECT SUMMARY/ABSTRACT
Supragingival dental plaque represents a degradative microbial community capable of fermenting a wide
variety of sugars over a wide range of concentrations while adapting to the constant changes in carbohydrate
source and availability in the oral cavity. Dental caries is developed due to a loss of balance between these
fermentative activities, which release corrosive organic acids, and the activities of the host and microorganisms
to neutralize acidic pH, resulting in a microbiome particularly good at producing and tolerating these acids. This
biochemical imbalance is frequently accompanied by a microbial dysbiosis, where the biofilm is predominated
by certain acid-producing and acid-tolerant species. Previous iterations of DE012236 established the
foundation for the present work by focusing on the integration of carbohydrate metabolism and virulence
development in the major caries etiological agent, Streptococcus mutans, in contrast to related commensal
streptococci such as Streptococcus sanguinis and Streptococcus gordonii. Further, by studying a spectrum of
sugar catabolism pathways, it was discovered that the mechanisms regulating sugar utilization in S. mutans,
e.g., carbohydrate catabolite repression (CCR), cheating and bet-hedging behavior, deviate substantially from
those of paradigm organisms. We posit that the deviation of S. mutans from these paradigms was driven by
evolutionary adaptations that have imparted to this organism the necessary degree of flexibility to respond to
the wide fluctuations in the amount and type of carbohydrates introduced into the human oral cavity. The
present proposal builds on these previous studies and our recent discoveries in fructose metabolism and
fructose-mediated cariogenicity and stress response, demonstrating the unique fitness of S. mutans that has
evolved to better utilize this ubiquitous carbohydrate to enhance its competitiveness against the commensals.
These fructose-specific phenotypes were further substantiated by the ability of fructose to activate in S. mutans
the core functions of stress response and as many as 176 gene shared with a toxic glycolytic byproduct,
methylglyoxal, including an uncharacterized conserved protein (GloA2) closely related to the enzyme required
for degradation of methylglyoxal. There's now a large body of high-quality research evidence associating
fructose with the ongoing epidemic of metabolic disorders: obesity, type 2 diabetes, cardiovascular diseases,
and liver pathologies. As the component of two most widely used dietary sweeteners, sucrose and high-
fructose corn syrup, fructose is likely contributing to the prevalence of caries among the western populations.
To understand the molecular basis for, and ecological consequences of, fructose metabolism in dental biofilms,
we present three Specific Aims: 1) In vitro characterization of the effects of fructose on streptococcal stress
physiology; 2) Identifying genetic mechanisms required for fructose and GloA2-mediated response in S.
mutans; 3) Assessing the contributions of fructose to microbial ecology and dysbiosis in biofilm models.

Public health relevance
PROJECT NARRATIVE Dental caries is an infectious disease that affects a large proportion of the world's population and that occurs when the tooth is damaged by bacteria on the tooth surface that produce acids from sugars. The goal of this research is to understand how the bacteria that cause caries coordinate the uptake and metabolism of sugars to optimize growth and acid production. The project has high public health relevance because of the widespread nature of dental caries, the high potential of the research to identify new opportunities for the prevention or treatment of caries, and the applicability of the knowledge generated to a variety of other important human pathogens.